Parent Training for Latinx Autistic Toddlers: Development and Preliminary Testing

PROJECT SUMMARY
Latinx children with diagnosed or suspected autism have especially long wait times for diagnoses and
intervention, up to a year or even more. This delayed access to intervention is likely to prevent children from
reaching their full potential in skills and adaptive functioning. A comprehensive, online mobile device-based,
free intervention that can be used by parents while on these wait lists may optimize their child's development.
We have developed such a program, the Online Parent Training in Early Intervention (OPT-In-Early) program.
It teaches parents the fundamental principles of both applied behavior analysis and naturalistic interventions,
uses non-technical language, video demonstrations, guidance in selecting appropriate skills to teach,
embedding teaching into daily routines, and reducing interfering behaviors. It is a self-paced, individualized
platform giving parents strategies to strengthen the parent-child relationship, to teach basic skills, such as
simple communication, to reduce interfering behaviors, and to establish helpful routines. In pilot the RCT,
parents (half of whom were self-identified as Latinx) rated the program very highly and showed positive
changes in behavior and knowledge.
The goal of the current project is to develop, and pilot test a bilingual Spanish/English culturally tailored
version of OPT-In-Early for Latinx families in the US. First, we will obtain detailed, iterative feedback from
bilingual Latinx parents with an autistic child regarding OPT-In-Early. We will use this feedback to culturally
adapt the program content and format. Next, we will modify the adapted program via user testing with Spanish-
speaking parents. Finally, we will test the bilingual version in a six-month pilot RCT, in preparation for a fully-
powered R01 trial. We will use a wait-list control design: the Intervention Now arm will be given the online
program and the Intervention Later arm (controls) will be given educational material about autism. All children
will receive a baseline and 6-month follow-up assessment, which will measure parent fidelity in using the
intervention principles (the primary outcome), child social communication, level of autism symptoms, impact of
autism symptoms, and degree of developmental delays.
At the conclusion of this research, we will have developed an evidence-based, comprehensive, freely
available, parent-delivered intervention that can be used by US Latinx families on their mobile devices as they
await diagnosis and intervention. This will increase parent efficacy and reduce their stress, accelerate
children's skills, reduce interfering behavior, and enhance PCPs' willingness to implement universal autism
screening.

Public health relevance
PROJECT NARRATIVE Young children with autism often have long wait times for diagnosis and intervention; this is especially true of children from Latinx families and may prevent these children from getting the earliest possible intervention. The proposed project will adapt and test a comprehensive, on-line, parent-mediated, free intervention (OPT-In- Early Bilingual Latinx Version) for Latinx families in the US; it can be used during these wait times and supplement professional intervention. Results of this study will lead to a large-scale test of this intervention, with the goal of making it freely available to Latinx families and optimizing their children's development.